Imaging Core

Imaging Core
Project Summary
Over the past decade there has been a revolution in imaging technology and its application to basic
biomedical research. The Imaging Core Module will be a critical resource in bringing this technology to the
vision research community at Yale. Advanced imaging equipment is expensive and typically cannot be
purchased and maintained with the resources of a single investigator. Moreover, with the nearly complete
conversion of imaging to advanced optics and digital methods, sophisticated data acquisition and analysis
techniques are required to quantitatively examine visual system structure, development and function. The
Yale Vision Core Program, through this Imaging module, will provide access to state-of-the-art imaging
technologies and the necessary training in advanced imaging approaches for vision investigators at Yale.
The Imaging Core module's primary goal is to facilitate the wide use of advanced optical and digital imaging
techniques within the Yale vision research community. This is achieved by three means. First, Yale School
of Medicine and the Departments of Neuroscience and Ophthalmology & Visual Science have made and
will continue to make a significant investment in advanced imaging microscopes, which Vision Core
investigators will gain free access to through the Yale Vision Core. Second, a Support Scientist, Dr. Stacy
Wilson, who is an expert in optics and digital imaging techniques, will provide technical support in the proper
use of the microscopes and digital imaging. Third, the Core module will train Vision Core scientists
(students, postdocs) in appropriate microscopy techniques and advanced digital image analysis. We
anticipate that the Imaging Core module will play an important role in the research success of vision
investigators at Yale University.